Research Training in the Epidemiology of Aging

Abstract
As the number of older people increases worldwide, the need for scientists and clinicians in aging research is
greater than ever with a critical need for interdisciplinary research on diseases and disabilities that affect a
more diverse older population. The objective of years 26-30 of this successful training program is to continue
training 5 pre- and 4 post-doctoral fellows to conduct independent and innovative original research in the
epidemiology of aging, with an emphasis on the prevention of late life disability and functional decline and the
maximization of function in those with existing disabilities and disabling conditions. The program emphasizes
four broad substantive areas in which program faculty have gerontologic research experience and are
conducting ongoing projects: musculoskeletal epidemiology; neuroepidemiology; genetic epidemiology and
genomics; and pharmacoepidemiology.
The program prepares trainees to: 1) participate in an interdisciplinary research team under supervision of a
primary mentor expert in the epidemiology of aging and secondary mentors expert in epidemiology methods
and/or biostatistics, gerontology, and content areas relevant to trainee research; 2) develop a research
question, articulate hypotheses, and design and perform an epidemiologic study; 3) become expert in one
substantive area relevant to the prevention of disability and functional decline; 4) demonstrate excellence in the
conduct of independent, innovative research; 5) gain experience in the presentation of research results, using
written, visual, and oral formats; 6) integrate a core curriculum in epidemiology, gerontology, and biostatistics;
7) master the principles of responsible conduct of research and scientific rigor and reproducibility; 8) apply
epidemiology of aging methods within clinical contexts; and 9) be prepared for the transition to a research
career in academia, government, industry, or non-profit sector using capabilities in the epidemiology of aging.
The program is located within the Department of Epidemiology and Public Health (EPH) of the University of
Maryland School of Medicine. Major program strengths include: 1) expert faculty in epidemiology of aging,
gerontology, biostatistics, and other substantive areas; 2) interdisciplinary training and research opportunities
in aging and related areas; 3) graduate training opportunities including advanced coursework through the four
supporting doctoral programs; 4) increased training of clinician scientists; 5) commitment to fostering inclusive
training; and 6) ability to capitalize on Baltimore/Washington corridor to leverage resources across multiple
domains (academia, government, industry, and non-profit). The highly qualified faculty and rich training
environment of our program are uniquely suited to provide this interdisciplinary approach needed to train the
next generation of scholars with a commitment to epidemiology of aging to find the solutions required to
improve the quality of life for older persons. The MPIs bring complementary expertise essential to the success
of the program; each has over 20 years of experience in interdisciplinary research, education, and mentorship.

Public health relevance
Relevance to Public Health The increasing life span is leading to greater numbers of older persons in the population. This training program is designed to prepare outstanding scientists to pursue topics that are relevant for understanding the health and functional status of an aging population, preventing the functional declines and disabilities that often accompany becoming older, and maximizing function in those with existing disabilities and disabling conditions.